PHYSIOLOGY AND PHARMACOLOGY OF SYNAPSES IN THE RETINA

PROJECT SUMMARY/ABSTRACT The overall objective of our research is to understand the detailed cellular and synaptic mechanisms underlying center and surround responses of retinal bipolar cells (BCs). Specifically, we will look at how neurons that mediate BC center and surround inputs in the outer retina (photoreceptors and horizontal cells (HCs)) interact with one another, and how adaptation, neuromodulators and the circadian clock regulate these cell-cell interactions and, consequently, BC receptive fields. We plan to use dual voltage clamp techniques to study cell-cell interactions at the photoreceptor, BC and HC levels, and use microelectrode voltage recording techniques to study receptive field properties of various types of cones, BCs and HCs. These two complementary approaches, along with the new knowledge and technical advances developed during the past years, will be applied to the salamander retina model system to study mechanisms underlying photoreceptor, HC and BC coupling and HC feedback/feedforward synaptic inputs to cones and BCs. These are common features of synaptic organization found in most vertebrate retinas. However, experiments involved in studying these features are technically difficult, if not impossible, to be carried out in many other vertebrates, including the mouse (thus issues to be addressed here complement, but do not overlap with our mouse grant). In this competing renewal application, we plan to continue our studies by focusing on 4 specific aims: (1) properties and modulation of electrical synapses between various pairs of photoreceptors (2 types of rods and 4 types of cones), (2) mechanisms underlying the sign-inverting, rod->cone transient signaling pathways in cones; (3) mechanisms underlying the depolarizing surround (feedback from HCs) responses in various types of cones; and (4) properties and modulation of HC and BC coupling and roles of cell-cell interaction in shaping BC and HC receptive fields. Results obtained will provide a detailed description of cell-cell interactions between neurons in the outer retina that are responsible for mediating the center and surround synaptic inputs in various types of BCs. Because of the similarities in outer retinal synaptic organizations between salamander and other vertebrates, knowledge obtained from this project will facilitate our understanding of how electrical/chemical synapses and BC receptive fields in mammalian and human retinas are organized, and provide important clues for developing animal models for various retinal diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Understanding how electrical and chemical synapses mediating receptive field organization in the outer retina is a fundamental and essential step for unraveling mechanisms of visual perception and brain operation. Results obtained from this project will provide crucial information on how specific defects in photoreceptor, bipolar cell and horizontal cell synapses are responsible for the onset of eye diseases, such as retinitis pigmentosa, macular degeneration, and congenital stationary night blindness. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The overall objective of our research is to understand the detailed cellular and synaptic mechanisms underlying center and surround responses of retinal bipolar cells (BCs), how neurons mediating BC center and surround inputs in the outer retina (photoreceptors and horizontal cells (HCs)) interact with one another, and how adaptation, neuromodulators and the circadian clock regulate these cell-cell interactions and BC receptive fields. During the past grant period, we have systematically studied physiological and morphological characteristics of 6 types of BCs in the dark-adapted salamander retina, and found that their center and surround responses are mediated by heterogeneous synaptic circuitry. We also characterized cell-cell coupling at the photoreceptor, HC and BC levels and voltage-gated currents in photoreceptors. In conjunction with previous findings on the salamander retina from our and other labs, these new results make the salamander retina a nearly-ideal preparation for studying synaptic circuitry underlying BC function, as this system provides a robust knowledge base on photoreceptor, HC and BC function/morphology as well as technical advantages very few other retinal preparations can match (see BACKGROUND section below). In this competing renewal application, we plan to continue our studies and focus on detailed cellular and synaptic mechanisms in the outer retina mediating BC center/surround responses. This application addresses 4 specific aims for in-depth analysis on interactions between photoreceptors, BCs and HCs, the rod->cone unidirectional transient signaling pathway, the HC->cone feedback synapses, and how adaptation, neuromodulators and the circadian clock modulate these cell-cell interactions and receptive fields. The issues to be addressed in this proposal do not overlap with the aims of our mouse grant (EY0199088, which proposes to study mammalian-specific rod and cone BC-AC-GC signaling pathways, expected funding date 12/01/09), and the majority of the proposed experiments in this application are technically difficult, if not impossible, to be carried out in the mouse retina (see discussion in BACKGROUND section). The 4 specific aims (Hypothesis to be tested by each aim is given in parenthesis) are: 1. How do various types of photoreceptors interact with one another? Is coupling between various types of rods and cones linear, reciprocal and symmetrical? What are the junctional conductances? How do adaptation, circadian clock and neuromodulators alter these synaptic interactions? (Hypothesis: Rod- rod coupling is strong, rod-cone coupling is weaker and its strength varies with the types of rods and cones involved, and cones are not coupled in the salamander retina. Similar to rod-rod coupling, coupling between various types of rod/cone pairs is largely linear, reciprocal and symmetrical. Flicker light adaptation, D-2 receptors, cAMP and circadian clock influence photoreceptor coupling in varying degrees.) 2. Does the sign-inverting, rod->cone transient signaling pathway exist in all cones? What are the reversal potential and ion dependence of this signal? Is it mediated by the horizontal cells (HCs)? If it is, A-, B-type or both? What synaptic mechanisms underlie this signaling pathway? (Hypothesis: the sign-inverting rod->cone transient signals exist in most cones, with a possible exception of the accessory member of double cones. It is mainly mediated by the B-type HCs and their axon terminals, via one or multiple chloride-dependent mechanisms, including those associated with hemichannels, pH, GABA and glutamate- transporters.) 3. Do all cones exhibit center-surround antagonistic receptive fields? What are the conductance changes associated with the surround depolarizing responses in various types of cones? Are surround responses in different types of cones mediated by different HCs and through different HC->cone feedback synaptic mechanisms? (Hypothesis: Different cones exhibit depolarizing surround (feedback) responses of different strengths. The surround responses in at least certain cones are associated with a conductance increase. The depolarizing surround responses in various types of cones are mediated by A-, B- type HCs or both, via one or multiple synaptic mechanisms, including those associated with hemichannels, pH, GABA and glutamate-transporters.) 4. How does HC-HC, BC-BC and HC-BC coupling affect BC receptive fields? What are the relative contributions of photoreceptor, BC and HC coupling to the BC and HC receptive fields? How do adaptation, the circadian clock and neuromodulators alter this cell-cell coupling and BC receptive fields? (Hypothesis: Homocellular BC and HC coupling are the primary determining factors for the BC and HC receptive field sizes. HC receptive field sizes affect the surround response strength of various types of BCs, and flicker light adaptation, circadian clock and D-1 receptor agonist/antagonists regulate coupling between various pairs of BCs and HCs to different degrees. Factors that regulate HC coupling alter BC surround responses).